CONFIRMATION OF HTLV-I OR HTLV-II PROVIRAL DNA SEQUENCES IN LYMPHOCYTE DNA BY PCR

Lymphocytes from 20 different donors were obtained from Abbott Laboratories and DNA extracted. The DNA samples were amplified with HTLV-I GAG primer pairs, GP1/GP2, HTLV-I POL primer pairs, SK54/SK55, HTLV-II POL primer pairs, SKSa/SK59 and SK1 IO/SKI I 1 and HTLV-II ENV primer pairs, SG638/SG639. The amplified DNA were hybridized with oligoprobes, GP3 for HTLV-I GAG, SK 56 for HTLV-I POL, SK 60 and SK 188 for HTLV-II POL and SG640 for HTLV-II ENV. The results showed that 8/20 DNA samples were positive for both HTLV-I GAG and POL gene sequences, 9/20 positive for HTLV-II POL and 9/20 positive for HTLV-II ENV gene sequences. 4/20 DNA samples showed no amplification with any of the primer pairs tested. By PCR analysis, eight samples were positive for HTLV-I, eight samples ere positive for HTLV-II and four samples were negative for HTLV-I or HTLV-II gene sequences. One of the HTLV-I positive samples cross reacted with HTLV-II POL probe SK188 and the other sample cross reacted with the ENV primers and probes.